Interrogating the cholinergic basis of opioid use disorder

ABSTRACT: Diversity Supplement, Interrogating the Cholinergic Basis of Opioid Use Disorder
Opioids offer unmatched clinical efficacy in the treatment of pain, yet produce equally harmful side effects that
can lead to opioid use disorder. Because traditional drugs impact all cells in a given volume, it has been difficult
to map cell type-specific contributions of drug-mediated behavior. To address this gap, we developed an opioid-
DART toolset, which makes it possible to deliver clinical opioids to genetically defined cells in behaving mice. In
our parent grant, we are now testing the hypothesis that opioid receptors on cholinergic interneurons mediate
the harmful (addictive) effects of opioids, independent of helpful (analgesic) effects. This Diversity Supplement
supports Lailah Ligons, a rising second-year graduate student, who will examine the cholinergic basis of opioid
use disorder with a focus on neural recording. In line with the parent proposal, Lailah's research will involve
employing DART technology and behavioral experiments. By focusing on neural recording, her work will provide
valuable insights into cell type-specific opioid effects and their impacts on neural activity. Ultimately, this research
will contribute to the development of novel therapeutic strategies and further our understanding of the complex
interplay between opioids and the brain. Moreover, by promoting diversity in the field of opioid
neuropharmacology, this supplement fosters an inclusive research environment and sets the stage for Ms.
Ligons to become a role model and future leader in the field.

Public health relevance
NARRATIVE: Diversity Supplement, Interrogating the Cholinergic Basis of Opioid Use Disorder We are developing and deploying a comprehensive toolset to enable cell-type-specific opioid pharmacology. In particular, we are testing the hypothesis that opioid receptors on cholinergic interneurons mediate harmful effects of opioids, independent of therapeutic analgesic effects. This Diversity Supplement supports Lailah Ligons, a rising second-year graduate student, in examining the cholinergic basis of opioid use disorder through a focus on neural recording. Her research will contribute to the development of novel therapeutic strategies and promote diversity in the field, positioning Ms. Ligons as a future leader and role model.